Synaptic Correlates of Vulnerability and Resilience to Alcohol Use Disorder

Although individuals with anxiety disorders are more likely to develop alcohol use disorder (AUD) than
healthy controls, the neural substrates responsible for this heightened risk are poorly understood. These
dual diagnoses are also associated with greater symptom severity of both disorders and poor treatment
outcomes. The central goal of this project is to employ neurobiological and behavioral approaches in rodent
models to identify neural circuit adaptations that play a causal role in promoting increased risk of developing
AUD and anxiety disorders. To that end, we have established a rodent adolescent social isolation model
(aSI) that engenders many behaviors associated with greater risk of developing AUD and anxiety disorders.
Relative to rats reared in groups throughout adolescence (aGH), aSI rats exhibit increases in anxiety-like
behaviors, novelty responding, impulsivity, and aggression in adulthood. aSI rats also display impaired fear
extinction and long-lasting increases in voluntary ethanol drinking. Neurobiological studies revealed that aSI
promotes increases in the excitability of glutamatergic projection neurons in the basolateral amygdala (BLA),
a brain region integral to anxiety-like and motivated behaviors, as well as increased synaptic activity in areas
that receive dense innervation from the BLA. It has also recently been discovered that BLA projection
neurons are not homogenous. Rather, these cells are distributed into two distinct clusters along the anterior-
posterior axis and form largely non-overlapping circuits in downstream brain regions. Activation of anterior
BLA (aBLA) circuits promotes aversion/anxiogenesis whereas activation of posterior BLA (pBLA) circuits
elicits rewarding/anxiolytic behaviors. Based on these findings, this project will test the hypothesis that aSI
shifts the excitatory/inhibitory balance between these opposing amygdala circuits, leading to excessive
excitability within aBLA pathways, and that these maladaptive changes play a causal role in the “addiction
vulnerable” phenotypes promoted by aSI. A secondary hypothesis to be investigated is that aSI promotes
similar adaptations in male and female rats but that the behavioral phenotypes that emerge are sexually
dimorphic. Additional studies will also seek to identify novel pharmacological approaches to restore normal
aBLA/pBLA excitability. Collectively, this project will provide critical new insight into the circuitry underlying
vulnerability to AUD and anxiety disorders and potentially lead to the identification of novel and much needed
treatments for individuals suffering from these frequently co-occurring diseases.
RELEVANCE (See instructions):
These studies will employ a rodent model that promotes an “addiction vulnerable” phenotype to identify
circuit-specific neural adaptations responsible for these behaviors. Studies will also seek to identify novel
interventions to reverse these maladaptive changes. Collectively, these studies will help to identify specific
neural pathways associated with AUD and comorbid anxiety disorders and potentially identify novel
treatments for individuals afflicted with these diseases.